BRAIN GLUCOSE METABOLISM DURING TASK PERFORMANCE AND PROLONGED SLEEP LOSS

This study will determine the effects of continuous sleep deprivation on concurrently measured brain glucose utilization, alertness, cognitive performance and mood; and on concurrently measured EEG, heart rate, core temperature, movement activity and circulating hormones and proteins (i.e., insulin, glucagon, glucose, tryptophan, tyrosine and melatonin).